2025 Inhibitions in the CNS Gordon Research Conference and Gordon Research Seminar

Project Summary
The next Gordon Research Conference (GRC) on inhibition in the Central Nervous System will be convened at
Sunday River in Newry, Maine, United States, on July 6-11, 2025. This international research conference has
been held every two years since 2005 as part of the GRC conference series. As in previous years, it will be
preceded on July 5-6, 2023, by the Gordon Research Seminar (GRS), which provides a unique atmosphere for
junior scientists, including postdocs and graduate students, to discuss and exchange novel findings and ideas
in preparation for the GRC. Inhibition in the Central Nervous System is mainly driven by the neurotransmitter
GABA, which has been proven to be fundamental for brain function and, when perturbed, it results in dysfunction.
A deeper understanding of inhibitory neurotransmission and its function in health and disease emerges centrally
in the design of novel therapeutic interventions for targeting inhibitory mechanisms to treat devastating brain
disorders, chiefly including neurological and child developmental disorders. Therefore, our application aligns well
with the mission statements of the National Institute of Neurological Disorders and Stroke (NINDS). GRC will
provide a major forum where leaders in the field and junior scientists who are rising new stars will have the
opportunity to exchange novel concepts and approaches to advance the field. The general scientific goal of this
meeting is to explore leading topics in the field of inhibition in healthy brains and to better understand the role of
altered inhibition in neurological and neuropsychiatric disorders. To achieve this goal, the meeting will pursue
the following specific aims: to select speakers that will discuss cutting-edge fundamental research questions in
inhibition within health and disease, to increase diversity and promote network collaborations, provide training,
networking and career promotion of graduate students and postdocs. The meeting will attain these aims by
selecting 34 world-class speakers and 10 discussion leaders, many of whom are junior group leaders from 10
different countries (24 US-based scientists, 23 women). These speakers are leading experts in inhibitory function
and dysfunction across model organisms (murine to human), brain areas (subcortical to cortical), levels of
investigations (molecules to systems) and approaches (experimental and computational). We will also introduce
new topics on rapidly emerging areas that were not covered in previous meetings. These include a topic on the
relationship between inhibition and adult neurogenesis, a session on inhibition in subcortical circuits and, and a
topic on computational modeling inhibitory function in healthy and diseases circuits. There is growing evidence
linking deficits of inhibitory function to neurodevelopmental and neurological disorders. As such, the GRC/GRS
meetings’ emphasis on health impact will maximize the discussion of fundamental questions in this field and
seek novel therapeutic targets of inhibitory circuitries to treat devastating brain disorders.

Public health relevance
Project Narrative The 2025 Gordon Research Conference on Inhibition in the Central Nervous System will bring together top international leaders and junior scientists to generate an inclusive environment to discuss the latest research and advance our knowledge in the field of inhibition. Particular emphasis will be placed on linking cutting-edge research into the roles of inhibition in healthy brain functions, such as learning and memory, and how disrupted inhibition plays a role in developmental and neurological disorders in humans. The conference will promote gender balance, enhance diversity, and will serve as an ideal venue for training of a new generation of young scientists in the field.